Host-associated biofilm formation and dispersal mechanisms

Abstract
Bacteria can form multi-cellular communities in which individual cells are protected from environmental
insults such as antibiotics by virtue of being [1] encased in a protective matrix comprised of polysaccharides
and other macromolecules and [2] physiologically distinct from free-living, planktonic cells. Biofilm formation
enhances the ability of bacteria to colonize surfaces, including host tissues and abiotic surfaces such as medical
implants, and seeds subsequent infections at distal locations through dispersal processes. As a result of these
characteristics, bacteria in biofilms are responsible for the majority of hospital-acquired infections and thus
understanding how biofilms form and disperse from such biofilms is critical. Although numerous animal
models of biofilm formation have been developed, few, if any, permit visual examination of biofilm formation
and dispersal events as well as a quantitative analysis of subsequent colonization outcomes. One such robust
model, however, can be found in the Vibrio fischeri-squid (Euprymna scolopes) symbiosis. To colonize, V.
fischeri first forms a biofilm on the surface of the symbiotic organ, then disperses from it to enter and
ultimately colonize sites deep within this organ. Our work has shown that genes required for biofilm formation
in laboratory culture are similarly required for host-associated (HA) biofilms and colonization, while genetic
changes that enhance biofilm formation in the lab also strikingly enhance HA biofilms and colonization. This
strong correlation affords us an exceptional opportunity to develop and test hypotheses about the mechanisms
of HA-biofilms, dispersal and subsequent colonization. Our work has revealed that HA biofilms and
colonization depend on syp, an 18-gene locus involved in production of SYP polysaccharide, and on multiple
sensor kinases and response regulators that control syp transcription and post-transcriptional events. We have
recently identified calcium (Ca2+) and nitric oxide (NO) as a strong inducer and inhibitor, respectively, of
biofilm formation. Ca2+ is a physiologically relevant signal that appears to affect numerous processes, but how
it does so is as-yet unknown. NO, which is produced by the squid and known to influence HA-biofilms, likely
impacts one of the sensor kinases required for syp transcription, and we propose to evaluate the underlying
mechanisms. We are also poised to identify other physiological signals that promote/inhibit HA biofilms. We
have recently uncovered conditions in which dispersal can be visualized in laboratory culture, and have
observed that V. fischeri undergoes multiple rounds of formation and dispersal in fully-grown cultures, a result
that suggests control by post-transcriptional mechanisms. We have begun to investigate that process by
identifying a set of genes involved in controlling dispersal. We propose to develop a mechanistic understanding
of these dispersal genes and the factors that control dispersal events as well as to search for others that we
predict to exist. We anticipate that this work will provide insights into the mechanisms by which bacteria
respond to their environment and transition in and out of multi-cellular communities within an animal host.

Public health relevance
Project Narrative Many if not most bacterial infectious diseases as well as the normal interactions between a human or animal host and its microbiome occur in the context of bacterial biofilms, communities of bacteria protected from host defenses as well as therapeutic antimicrobials. We study the symbiosis between the bacterium Vibrio fischeri and a squid as a simple animal model that permits us to readily visualize host (animal)-associated biofilm formation and dispersal, an event that permits bacteria to spread, and evaluate the underlying mechanisms. We are poised here to investigate signals and processes that promote host-associated biofilms and dispersal, and anticipate that our ability to readily investigate how bacteria enter and leave biofilms in the context of an animal will promote our ability to treat infectious biofilms in the context of human disease.